Core A: Administrative Core

The Administrative Core will develop and maintain the overarching organizational and administrative structure
for all the ADRC cores, developmental projects, and related activities under the leadership of Director Bruce
Miller and Associate Director Gil Rabinovici. The Administrative Core will drive and direct the internal
integration across all cores, including the Clinical Core, the Data Management and Statistical Core, the
Neuropathology Core, the Outreach Education and Engagement Core, the Neuroimaging Core, the Biomarker
Core, the novel Research Education Component, and the three developmental projects as they are
implemented. Essential activities include promoting and supporting new and ongoing collaborations critical to
advancing research while introducing new trainees and investigators to the field. The Administrative Core will
carefully oversee and follow all applicable regulatory and fiscal controls. The core serves as the primary liaison
between the center and other entities that inform our research and strategic planning process, including the
faculty/staff, the External Advisory Committee, our Community Advisory Board, and our Family/Caregiver
Advisory Council. The Administrative Core will work locally to garner institutional resources while stimulating
collaborations across UCSF. A major effort is focused on maintaining an active and productive engagement
with community partners and both national and international collaborators. Key operational functions include
providing communication tools and efficient services for fostering innovative research, training, sharing
resources, coordinating progress, disseminating knowledge, fiscal management, and reporting. The
administrative team will guide strategic planning, program monitoring and evaluations, and responsive
improvements.

Public health relevance
PROJECT NARRATIVE The ADRC will benefit public health through advancing knowledge of clinical diagnostic processes, genomic, basic, translational, and clinicopathological research regarding prevalent neurodegenerative diseases and common cognitive disorders of aging.